Novel membrane defense systems utilized by the human pathogen Leishmania

PROJECT ABSTRACT
The anti-Leishmaniasis drug amphotericin B has a low therapeutic index, which may be due to protection of
ergosterol in the Leishmania plasma membrane. The extent to which Leishmania hides its ergosterol and how it
reseals its membrane have never been examined. Thus, there is a critical need to determine the mechanisms
by which Leishmania protect their sterols to prevent membrane damage, and by which they reseal damaged
membranes. Without this information, the full potential of anti-ergosterol drugs like amphotericin B will not be
realized, and improved membrane disrupting strategies will not be identified. The long-term goal is to identify
membrane mechanisms and lipids in Leishmania that will provide high selectivity for controlling the parasite. The
overall goal is to identify the mechanisms Leishmania use to prevent and reseal membrane damage. The central
hypothesis is that Leishmania prevent membrane damage by protecting ergosterol from access to sterol-binding
toxins and drugs via the primary Leishmania sphingolipid, inositol phosphorylceramide (IPC), and potently
reseals membrane damage via Ca2+-independent repair. The rationale for the project is that Leishmania are
genetically tractable protozoa evolutionarily distinct from mammals that are likely to provide key insights into
resisting and resealing plasma membrane damage. Determining the differences in membrane defense and repair
between Leishmania and mammals will provide a strong scientific framework in which existing anti-Leishmania
therapies can be improved, and new therapies developed. To attain the objectives, these specific aims will be
pursued: 1) Determine the mechanisms that reduce membrane damage in Leishmania, and 2) Determine the
mechanisms that promote membrane repair in Leishmania. In Aim 1, the working hypothesis that Leishmania
prevent membrane damage by sheltering vulnerable sterols under IPC will be tested by challenging L. major
promastigotes genetically or enzymatically lacking sphingolipids, phospholipids or virulence factors with sterol-
binding toxins or detergents and measuring sterol accessibility, toxin binding, and lethality by flow cytometry. In
Aim 2, the working hypothesis that Leishmania reseal their membrane using Ca2+ independent, ESCRT-
dependent shedding of damaged membranes will be tested by measuring membrane shedding, patch repair and
ESCRT trafficking in toxin-challenged L. major expressing GFP-tagged ESCRT proteins by flow cytometry,
ultracentrifugation, and live cell imaging. The expected outcomes of completing this work are to have defined
the mechanisms by which Leishmania protect their sterols from attack, and membrane repair pathways that
restore homeostasis in human pathogens evolutionarily distant from mammals. The proposed research is
innovative because it departs from the status quo by revealing new paradigms of sterol accessibility and
membrane repair. These results will have a positive impact because a better understanding of how Leishmania
protect their membrane will provide new drug targets. Targeting protective mechanisms in Leishmania may
potentiate drugs like amphotericin B, and provide a selective target for Leishmania and other protozoa.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because the protozoan parasite Leishmania protects its membranes differently than mammalian cells, but it is unclear how or why. This project will define the membrane organization of Leishmania so that we can develop new treatments for the neglected tropical disease Leishmaniasis. Therefore, the proposed research is relevant to the NIH’s mission to reduce disability and illness.